Molecular Biology Of Mast Cell Growth &Differentiation

We have developed human mast cell (HuMC) lines termed Laboratory of Allergic Diseases(LAD) 1 and 2 which are dependent upon stem cell factor, have the appearance of mature cells, and degranulate following aggregation of Fc gamma RI on their surface. LAD cell lines do not appear to have mutations in KIT. In collaboration with Dr. Nilsson, we have also documented and characterized two sublines of HMC-1 cells which vary in mutations in KIT and vary in phenotype. Together, these cell lines provide a means to study the biology of HuMC without the need to culture HuMC from precursors in blood or marrow. Thrombopoietin (TPO) is a hepatocyte-derived growth factor known to promote platelet number, to have growth-promoting potential for megakaryocytes (MKs), and to promote erythrocyte, monocyte, mast cell, and granulocyte proliferation in the presence of specific growth factors. To explore the ability of TPO alone to support mast cell proliferation, we cultured CD34+ cells in rhTPO under conditions developed to culture MKs and examined these cultures for the presence of HuMCs. Similarly, we added rhTPO to CD34+ cells cultured in stem cell factor, known to promote HuMC development. Using serum-free media (SFM) supplemented with rhTPO, human CD34+ cells at 2-3 weeks differentiated into MKs (85-90%) and (5-10%) poorly differentiated HuMC. SCF-independent HuMCs expressed TPO (c-Mpl) receptors, tryptase and chymase; and were capable of surviving in SFM with rhTPO alone, or proliferating when recultured in rhSCF. Small numbers of HuMC were noted when rhTPO was combined with 10 ng/ml rhSCF. However, in HuMC cultures with 100 ng/ml rhSCF, the addition of 50 ng/ml rhTPO significantly reduced HuMC numbers, with the appearance of MKs. Under all conditions, the addition of TPO favored the growth of KIT-low HuMC. Thus, the effect of TPO on SCF-dependent HuMC varies depending on the concentration of cytokines, with higher doses of rhTPO favoring MK proliferation.